Research Experience and Training Coordination Core

Project Summary. The RETCC has played a coordinating role in the success of ULSRC since its inception in
September 2017. By working closely with other NIEHS-supported training programs at the UofL (T32ES011564;
T35ES014559), the RETCC has developed a rich, diverse, and comprehensive training program that is both
multidisciplinary and inclusive. In addition to the course work and ‘on the bench’ training activities, RETCC
routinely organizes participatory field trips to the Lee’s Lane Superfund site to better understand and appreciate
health concerns of residents in the adjacent community of Riverside Gardens; facilitates the meeting of trainees
with regional Superfund site coordinators and officials and the Metro Louisville Public Health and Wellness
Department. Our training core in collaboration with Superfund Research Centers at Duke University, University
of Kentucky, and University of Pennsylvania organized a trip to Washington, D.C. so trainees could attend a
Science and Policy Institute meeting that included interactions with congressional leaders and their staff. Such
activities have been instrumental in the well-rounded growth of our trainees. Moreover, these trainees not only
provide “the force that turns the wheel” but also are the focus and hub of intellectual crosstalk and fertilization
across projects, cores, other SRCs and the National SRP. To date, ULSRC success is the product of our trainees’
successes through their many accomplishments including publications, presentations, awards, degrees,
fellowships, interactions with community partners, and environmental health sciences-related career
opportunities. Thus, although we are proud of our current success via integration of trainee activities across the
ULSRC, we continue to strive to build on these successes by implementing innovative and unifying features into
RETCC-directed activities that focus on fulfilling the goals and furthering the success of our trainees.

Public health relevance
Relevance: The overall goal of the Research Experience and Training Coordination Core (RETCC) is to direct successful training of graduate students and post-doctoral fellows (designated ‘trainees’) in the University of Louisville Superfund Research Center (ULSRC). This includes scientific interdisciplinary training within defined ULSRC projects and cores as well as promoting development of a broad knowledge base and the skills needed to communicate and engage with relevant community partners, government liaisons and health-care professionals regarding the importance of environmental health sciences research in the Superfund Program.